Total-body PET Parametric Imaging using Relative Patlak Plot

Project Abstract/Summary Positron emission tomography (PET) with 18F-fluorodeoxyglucose (FDG) is an
advanced molecular imaging technique to measure metabolic activities within the human body. Unlike standard
static PET, which yields a semi-quantitative standard uptake value (SUV) for quantification, dynamic PET imaging
combined with tracer kinetic modeling enables parametric imaging, offering critical physiological information such
as metabolic rate. The standard Patlak plot, a simple yet efficient linear model, is widely used to describe FDG
kinetics. The resulting slope parameter 𝐾i, which represents the FDG influx rate, has demonstrated significant
advantages for cancer diagnosis and therapy assessment compared to SUV alone. Whole-body parametric
imaging with the standard Patlak plot has been implemented on conventional PET scanners with an axial field-
of-view (AFOV) ranging from 15-30 cm using a multi-bed and multi-pass acquisition strategy. The advent of total-
body PET scanners with an AFOV greater than 1 meter, such as UIH EXPLORER and Siemens Quadra, has
further simplified and improved the implementation for standard Patlak parametric imaging because of much-
improved detection sensitivity and simultaneous coverage of multiple organs. However, despite these
advancements, the full-time dynamic scan duration (e.g., 1 hour) has remained the same due to the need for an
image-derived blood input function. In this project, we aim to develop an efficient total-body PET parametric
imaging approach that can be applied to a short dynamic scan regenerated from the routine clinical static scan
(e.g., a 20-minute or shorter scan at 1-hour post-injection). The enabling approach uses a Relative Patlak (RP)
plot that does not require the early-time input function. The RP plot has recently been deployed on GE
commercial scanners. Our early study and another recent clinical study have demonstrated the equivalence
between the RP slope 𝐾i′ and the standard Patlak 𝐾i in clinically relevant tasks, such as lesion detection and
tumor volume segmentation. However, one major challenge of applying this approach is the higher noise level
in parametric images when the scan duration is shortened. Our preliminary work has indicated the potential of
shortening the scan duration to 20 minutes for RP parametric imaging, making it possible to be directly applied
to clinical static scans. The specific aims of this proposal are to further develop the enabling technique, push the
method for shorter scans (e.g., 10 minutes), and evaluate the benefits of RP parametric images on top of SUV.
Specifically, we will (1) develop a deep learning solution for improving RP parametric imaging within a shortened
scan duration and (2) evaluate the benefits of RP parametric images on top of SUV using clinical cohorts.
Completing these specific aims will improve the diagnosis and comfort of patients by providing an efficient total-
body PET parametric imaging approach that is adaptive to clinical static scan protocols without adding any
imaging time and scan costs. Our proposed approach will offer a unique solution for pediatric parametric imaging,
as the full-time dynamic scan is impractical for pediatric patients.

Public health relevance
Project Narrative This project aims to utilize the Relative Patlak plot to develop an efficient total-body PET parametric imaging approach that can be directly applied to a shortened dynamic data regenerated from the routine clinical static scan. The new parameters obtained from this approach will provide valuable information to complement SUV for clinical decision-making in standard-of-care practice without adding imaging time and scan costs.